Kansas Maintenance of the Animal Feed Regulatory Program Standards with Optional Coordinated Preventative Control

Project Summary
The Kansas Department of Agriculture (KDA) Feed Safety Program’s aim is to maintain and
improve its national, fully integrated food safety system by continuing full conformance with the
Animal Feed Regulatory Program Standards (AFRPS). The KDA Feed Safety Program will
accomplish this through self-assessment, training, auditing, enforcement, and outreach. In
addition, the KDA Feed Safety Program will continue to further develop its Preventive Controls
for Animal Food Initiative through enhanced training, education and outreach. By implementing
both AFRPS and PCAF, the KDA Feed Safety Program will be able to seamlessly establish a
uniform application for management alongside its regulatory partners which is essential in
achieving an integrated national feed safety system.

Public health relevance
Project Narrative By participating in this cooperative agreement, the Kansas Department of Agriculture (KDA) Feed Safety Program will aim to successfully maintain and continue to improve the Animal Feed Regulatory Standards (AFRPS) set forth by the FDA. In addition, the KDA Feed Safety Program will further develop the state’s Preventive Control (PC) regulatory work by enhancing its ability perform Current Good Manufacturing Practice (CGMP) & PC inspections under 21 CFR Part 507. The KDA Feed Safety Program aims to ensure a safer feed supply without adversely impacting the manufacturers of animal feed within the state of Kanas.